Center for Pediatric Brain Health

Abstract/Summary: Overall Component
This application for a Center of Biomedical Research Excellence (COBRE) would initiate a Center for Pediatric
Brain Health to manage, support, and expand developmental neuroimaging and pediatric neuroscience research
at Boys Town National Research Hospital (BTNRH) in Omaha, Nebraska. It is an opportune moment for pediatric
neuroscience at BTNRH, as an organization-wide initiative to expand in this area has resulted in numerous
faculty hires and the construction of a new state-of-the-art 15,000+ square feet Institute for Human Neuroscience.
The proposed Center for Pediatric Brain Health will organize and support these new resources under a central
umbrella, and provide critical programs to help grow the community and build cohesiveness around a common
theme of pediatric neuroscience and brain health. The key components of the Center include an Administrative
Core, one research core (i.e., the Neural Quantification & Imaging Core), four research project leaders (RPLs),
a Supervisory & Mentoring Committee, and a cohort of established pediatric neuroscientists. Upon initiation of
the Center, the Administrative Core will implement a comprehensive research support structure that includes
mentoring and career developing resources, a pilot projects program, extensive training opportunities, two
distinct seminar series, community outreach, and broad support of key research infrastructure (e.g., participant
registry, shared research spaces). Training opportunities will include technical workshops, as well as internships
and a postdoctoral neuroimaging training program for fostering the next generation of graduate students and
Center faculty. In parallel, the Administrative Core will promote the launch of four RPLs and implement a career
development and evaluation system, which will include a Supervisory & Mentoring Committee comprised of 10
senior scientists who will monitor progress and ensure each RPL and their two co-mentors reach critical
milestones. Finally, the new Neural Quantification & Imaging Core will support and provide direct access to state-
of-the-art instrumentation for pediatric neuroimaging, including a new 3-Tesla Siemens Prisma magnet, two Neo
magnetoencephalographic (MEG) imaging units, a mock MRI scanner, and other major equipment, and will
provide comprehensive analytical support for the most advanced neuroimaging analyses currently available.
Notably, the Core will be the only site in the world to host two MEG Neo systems for quantifying human brain
dynamics. The new Center will also support a cohort of senior scientists with expertise spanning multiple pediatric
populations and different imaging technologies. Finally, the Center will receive exceptional institutional support,
including funds for pilot projects, Core staffing, internships, major equipment expenses, and other initiatives, and
will be directed by Dr. Tony Wilson who is a developmental cognitive neuroscientist with extensive experience
in multimodal neuroimaging and an exceptional track record of extramural support, publications, and mentoring.
Taken together, the expansive resources, support, and expertise within the new Center for Pediatric Brain Health
will ensure that it has a major long-term impact on pediatric neuroscience research at BTNRH and beyond.

Public health relevance
Project Narrative: Overall Component This application would initiate a Center of Biomedical Research Excellence (COBRE) at Boys Town National Research Hospital in Omaha, Nebraska, with a focus on pediatric neuroscience, developmental neuroimaging, and brain health. The Center for Pediatric Brain Health would include an Administrative Core that oversees a series of integrated support programs, an advanced Neural Quantification & Imaging Core Facility, a Supervisory & Mentoring Committee, four COBRE research project leaders, and an established cohort of senior investigators. The Center would leverage major recent growth in staff and facilities through Boys Town’s pediatric neuroscience initiative, and continue the organization’s mission to change the way America cares for children and families.